Determination of Route of Administration and Cardiac Safety of a Novel Psychoplastogen for the treatment of SUDs

ABSTRACT
Delix Therapeutics is developing psychoplastogens, compounds that promote rapid and sustained
neuroplasticity. This new class of compounds was identified by Delix founder, Professor David Olson (UC Davis).
DLX-007 is a novel, potent psychoplastogen designed and inspired by known psychoplastogens Ibogaine and
5-MeO-DMT. Similar to these clinically effective compounds, DLX-007 promotes structural and functional neural
plasticity in circuits relevant for the treatment of substance use disorders (SUDs) with demonstrated efficacy for
a variety of substances in preclinical models including opioid use disorder (OUD). In addition to reducing heroin-
consumption and producing antidepressant-like effects in rodent, DLX-007 avoids many of the safety concerns
abundant to ibogaine.
DLX-007 has completed GLP IND-enabling studies, showing a good safety profile and desired effect in relevant
preclinical models of OUD. In order to further advance the development of DLX-007 and position it for transition
to human trials, Delix proposes to establish the ideal administration profile, while maintaining acceptable
cardiotoxic safety, for the treatment of humans. In this proposal, we will first assess the ideal route of
administration by establishing the pharmacokinetic (PK) parameters of intramuscular administration in three
preclinical species, modelling the predicted human PK and comparing those results to previously obtained PK
parameters for intravenous and oral administration. Secondly, we will use a state-of-the-art cardiovascular safety
assay to validate and expand the comparative improvements our compound has in relation to ibogaine’s
notorious cardio-safety profile.
This proposal introduces a novel treatment paradigm for SUD, namely, leveraging structural plasticity. Delix’s
DLX-007 is a high potential therapeutic for OUD, preserving its neuroplastic promoting characteristics and
behavioral efficacy of ibogaine but without the hallucinogenic liabilities and reduced cardiotoxic liabilities. DLX-
007 treatment may reverse opioid-induced structural changes and its clinical development could enhance the
therapeutic arsenal for treating OUD, in particular because it provides a non-opioid receptor-based therapeutic
that might be capable of reversing the underlying disease neuropathology long-term. Due to DLX-007’s improved
safety profile relative to its parent compound, we anticipate that DLX-007 may also have broad therapeutic
potential for treating multiple SUDs in addition to other neuropsychiatric and neurodegenerative disorders
characterized by dendritic spine and synapse loss in the PFC and its downstream targets.

Public health relevance
NARRATIVE Delix Therapeutics is developing a psychoplastogen compound which is safer than existing treatments for substance use disorders (SUD), while maintaining a remarkable therapeutic potential. DLX-007, an ibogaine analog, has shown to positively modify substance seeking behavior and affect neural plasticity in preclinical models, while remaining non-hallucinogenic and non-cardiotoxic, safety concerns associated with ibogaine.